Formation and Repair Mechanisms of DNA-Protein Cross-Links, and Functions and Regulatory Mechanisms of TREX1 in DNA Repair

Abstract
Understanding how DNA is damaged and how the damage is repaired is critical. This is because DNA damage
contributes to genome instability, aging, and diseases, and DNA-damaging agents are used in chemotherapy.
Covalent DNA-protein cross-links (DPCs) are ubiquitous and bulky DNA lesions. Despite that it has been well
accepted that DPCs are highly toxic, compared to other types of DNA damage, DPCs are much less well studied
mainly due to the lack of approaches to detect, quantify, and synthesize DPCs. My research program studies
DPCs at 3′-DNA termini (3′-DPCs) within single-strand breaks (SSBs). They are derived from the
apurinic/apyrimidinic (AP) site that is one of the most frequently formed DNA lesions and induced by many
endogenous and exogenous genotoxins including some anti-cancer drugs. If left unrepaired, 3′-DPCs will block
DNA replication and transcription, prevent the SSB repair, cause genome instability, and may lead to cell death.
We hypothesize that 3′-DPC formation is a previously uncharacterized cytotoxic mechanism of the AP site and
its inducing agents, 3′-DPCs are new biomarkers of oxidative stress-related diseases, and inhibiting 3′-DPC
repair will synergize DNA methylating agents. Our goal is to elucidate the formation and repair mechanisms of
3′-DPCs. In past work, we have detected 3′-DPCs in human cells using a novel mass spectrometry pipeline, but
their cellular abundance and to what extent they are induced by genotoxins are unknown. We have chemically
synthesized 3′-DPCs and demonstrated that they can be repaired by three human nucleases, but only when the
cross-linked proteins are initially digested by trypsin. How 3′-DPCs are proteolyzed in cells remains elusive. We
will fill these knowledge gaps. Notably, during studying 3′-DPC repair, we discovered in vitro that proteolyzed 3′-
DPCs and an AP site repair intermediate (i.e., 3′-PUA) are excised by human three-prime repair exonuclease 1
(TREX1). This unexpected finding is the first to report a direct role of TREX1 in DNA repair and challenges the
previous notion. It opened a new and exciting research direction that we will also pursue in this MIRA application.
Our hypothesis is that TREX1 is a 3′-DNA lesion processing enzyme and a promising therapeutic target. Our
goal is to delineate the functions and regulatory mechanisms of TREX1 in DNA repair. We will focus on several
important questions. For instance, does TREX1 play a role in cells in response to DNA damage? If so, is that
dependent on its exonuclease activity? And how is TREX1 recruited and regulated? We will address these
questions and study 3′-DPC formation and repair mechanisms using interdisciplinary techniques including
organic synthesis, quantitative mass spectrometry, proteomics, biochemistry, molecular and cell biology-based
approaches. This research will advance fundamental understanding of DNA damage and repair. Such new
knowledge will inform the development of novel therapeutic interventions.

Public health relevance
Narrative DNA-protein cross-links at 3′-DNA termini arising from apurinic/apyrimidinic sites that are induced by various endogenous and exogenous genotoxins, if not repaired, can have toxic effects and may lead to cell death. TREX1, the major human 3′ to 5′ exonuclease, has an unexpected role in processing DNA lesions at 3′-termini. We propose to study the formation and repair mechanisms of these DNA-protein cross-links, and investigate the functions and regulatory mechanisms of TREX1 in DNA repair.